The role of novelty and surprise in aversive learning

Abstract of Funded Project
Novelty and surprise have long been known to facilitate learning and memory. At a functional level this
makes sense; unexpected events have to be learned about so they can be predicted and responded to
appropriately in the future. At a psychological level, surprising events have been shown to enhance
memory because they induce rehearsal. Subjects tend to “think about” unexpected events more than
familiar ones after they occur. This has been observed directly in humans (explicit rehearsal) and
indirectly in animals (implicit rehearsal). In both cases, the memory enhancement can be eliminated by
disrupting rehearsal with a distractor stimulus that is presented immediately after the novel event.
Presenting the same distractor stimulus several minutes later has no eGect. This suggests rehearsal is
short-lasting and distinct from the process of memory consolidation, which stabilizes new information
for several hours after learning. In addition to increasing rehearsal, novel events also trigger the release of
norepinephrine (NE) and dopamine (DA), which are known to enhance synaptic plasticity. Blocking
receptors for these neuromodulators in the hippocampus prevents animals from forming new spatial and
contextual memories. Based on these ﬁndings, we hypothesize that surprising events enhance memory
because they induce catecholamine release at the same time the hippocampus is actively
rehearsing/replaying new information. Our preliminary data demonstrate that NE and DA are both
released in the hippocampus during and after the presentation of an unexpected aversive stimulus. At
the same time, there is an increase in sharp-wave ripple oscillations (SWRs), which are known to contain
replay sequences for recently encountered stimuli. Consequently, we will test the hypothesis above by
monitoring and manipulating catecholamine release in real-time during an aversive learning task while
simultaneously recording oscillations and single unit activity in the hippocampus.
Abstract of Proposed Research Project
Savannah is a third year Neuroscience graduate student who started working in my lab in March, 2023.
She arrived with experience performing behavioral assays in mice, but little experience imaging and
manipulating neural activity in vivo. During the training period, Savannah will use ﬁber photometry and
optogenetic techniques to monitor and manipulate the activity of dopaminergic neurons in the VTA
during an aversive learning task that depends in the hippocampus (trace fear conditioning). In previous
studies (proposed in the parent RO1), we used these techniques to image activity and induce DA release
in the hippocampus by stimulating LC neurons during trace fear conditioning. This work revealed that the
LC was the primary source of the observed DA signal in dorsal CA1 during aversive learning. It also
showed that DA functioned as a salience signal and did not appear to convey information about
prediction errors. In addition to the LC, these experiments demonstrated that there was a small, but
signiﬁcant, amount of DA released into dorsal CA1 from the VTA (Figure 1A). This is consistent with the
recent ﬁnding that a small population of dopaminergic neurons in the VTA respond to aversive stimuli1,2.
Similar to data we obtained in the LC, lesioning the VTA produced a signiﬁcant long-term memory deﬁcit
in TFC (Figure 1B). Based on these data, the goal of the current project is to: 1) examine how
dopaminergic neurons in the VTA (and their terminals in dorsal CA1) respond during TFC 2) determine the
eGects of VTA stimulation on dopamine release in dorsal CA1 as well as long-term memory formation.
These experiments will extend the ﬁndings of the parent grant by determining if DA release by the VTA
plays a distinct role in hippocampus-dependent learning and memory.

Public health relevance
Project narrative Fear and anxiety underlie the most common forms of mental illness in the United States, with more than 30% of Americans experiencing an emotional disorder at some point in their life. Consequently, a major goal of NIH is to understand the neural mechanisms that underlie adaptive and maladaptive threat processing. The hippocampus and dopamine release (via the locus coeruleus and ventral tegmental area) both contribute to fear and anxiety, but it is not known how they interact during these states to promote the encoding of aversive memories. This represents a major gap in our understanding of the neural systems that contribute to emotional disorders. Altered catecholamine release accompanies schizophrenia, bipolar disorder, and ADHD, which are often comorbid with fear and anxiety disorders. Alzheimer’s disease also produces severe atrophy of the locus coeruleus, which reduces catecholamine release throughout the brain and is thought to exacerbate amnesia. To determine how altered catecholamine levels impact these disorders, it is essential to establish the basic mechanisms by which neuromodulatory inputs to the hippocampus regulate the formation of aversive memories.